Tele-resistance training during chemotherapy for advanced upper gastrointestinal cancer

PROJECT SUMMARY
Resistance training can improve fitness, clinical, and quality of life outcomes during cancer treatment.
Individuals with advanced upper gastrointestinal (GI) cancers frequently present with skeletal muscle loss that
may worsen during chemotherapy. Resistance training may be beneficial in this context, but its feasibility and
effectiveness have not been established. Home-based exercise programs may be preferable for many cancer
survivors, including those who receive treatment near home and face barriers such as time, finances, and
disease pandemics that complicate participation in supervised programs at cancer centers or other fitness
facilities. Adherence to our resistance training recommendation in a previous, home-based exercise
intervention during pancreatic cancer treatment was poor. Participants cited factors such as lack of familiarity
and low social support as barriers to resistance training. The purpose of this project is to “bridge” the
convenience of and preference for home-based resistance training to the support and supervision of in-person
resistance training by developing a virtual, or “tele-resistance training” (“tele-RT”) approach. We also aim to
compare changes in muscular strength and endurance, skeletal muscle health, health-related quality of life,
fatigue, and physical functioning between individuals randomized to participate in tele-RT and individuals
randomized to receive usual care during first-line chemotherapy. We hypothesize that the intervention will be
feasible, safe, and acceptable and that participation will be associated with improvements in outcome
measures compared to usual care. Individuals undergoing first-line chemotherapy for advanced upper GI
cancer (N=100) will be randomized to receive usual care vs. engage in tele-resistance training supervised by
certified trainers using video conferencing software and tablet computers. Exercise prescriptions will be
individually-tailored and supervised to safely increase strength over time. Feasibility (enrollment, retention, and
adherence to exercise sessions and prescribed exercise volumes) and safety will be monitored by trainers.
Acceptability will be rated via questionnaire following participation. Participants will complete measures of
muscular strength and endurance, skeletal muscle health, health-related quality of life, fatigue, and physical
functioning prior to and following first-line chemotherapy (approximately 3 months). Resistance training has
important potential to improve health and well-being for individuals with advanced cancer, but these benefits
depend on adherence. In this project, we aim to evaluate a novel strategy to encourage resistance training
adherence by providing virtual supervision. This intervention has broad potential to encourage resistance
training and elicit benefits among individuals in various cancer survivorship contexts.

Public health relevance
PROJECT NARRATIVE Slowing muscle loss and increasing strength and physical function may be important to increasing health- related quality of life among individuals undergoing chemotherapy for advanced upper gastrointestinal cancers. We aim to test the feasibility, safety, and acceptability of a home-based, “tele-resistance training” program in which patients will engage in exercise sessions via video conferences with certified trainers. We will compare changes in fitness, muscle health, health-related quality of life, fatigue, and physical functioning between patients participating in tele-RT and patients who have no exercise program to better understand the value of exercise in this context.